Organization and architecture of a Center for cellular resolution analysis of Alzheimer's disease

ABSTRACT (ADMIN CORE)
The Center proposal “A platform for cell type-level transcriptomic, epigenomic and spatial interrogation of
Alzheimer’s disease” proposal aims to combine expertise in AD pathology with expertise in new single cell
molecular technologies to generate a new high resolution cellular and molecular understanding of the early
pathogenesis of AD. The Center consists of three Research Projects, focusing on neuropathology,
transcriptomics and epigenomics, and spatial transcriptomics; a Data Core, and an Administrative Core with
seven PIs and three collaborative sites. Realizing the potential of this Center requires strong administrative
leadership to integrate and synergize efforts across the collaborating researchers at the University of
Washington, Kaiser/Group Health and the Allen Institute for Brain Science.
The Administrative Core will provide the structure, leadership and operational management of the Center
towards achievement of the overall Center goals to understand the cellular and molecular basis of the early
pathogenesis of AD. This will include project management, strategic planning, progress reporting, fiscal
management, and support for collaboration and communication. The Administrative Core will create an
infrastructure that fosters communication and collaboration among the Center members, as well as garnering
input from the external AD research community through the formation of an External Scientific Advisory
committee. The Center will form a Steering Committee and Project Teams to oversee the collaborative,
standardized, and on-time data generation, data analysis, and public data sharing process. Project management
best practices, such as milestones, progress reporting and tracking, collaborative software programs, and a
responsibility matrix will be applied to the Center to ensure achievement of performance objectives and
milestones, optimized communication, and resource utilization and prioritization. In addition, the Core will foster
joint data analysis efforts across projects and Institutions, including joint Analysis Working Groups and
hackathons. Further, the Administrative Core will support the implementation of standard operating procedures
and quality control standards for data generation, data processing, and analysis. To produce a high-quality data
resource for high resolution neuropathological and omics analysis of Alzheimer’s disease, rigorous
standardization and quality control practices will be adopted by all members. Finally, the Administrative Core will
implement and maintain fiscal and subcontractor management processes for all members, manage publication
and authorship decisions and conflict resolution. With the implementation of this entire infrastructure, we
anticipate that this project and the resources it produces will have a broad and meaningful impact on gaining a
deep molecular and cellular understanding of Alzheimer’s disease pathology and progression.

Public health relevance
PROJECT NARRATIVE (ADMIN CORE) The Administrative Core will provide the leadership and organizational structure to align the efforts of the individual Institutions, projects and researchers to meet the Center goals and milestones. This will involve integrating and aligning the efforts of the three Research Projects (neuropathology, transcriptomics and epigenomics, and spatial transcriptomics) and the Data Core. The Administrative Core will oversee the operational management including strategic planning, project management, progress reporting, fiscal management, manuscript and authorship planning, conflict resolution and support for collaboration and communication to create, integrate, and disseminate to the community a molecular and cellular understanding of Alzheimer’s disease.